Data Coordinating Center for the Nonalcoholic Steatohepatitis Clinical Research Network (NASH CRN) Continuation

Data Coordinating Center for the NASH Clinical Research Network (NASH CRN)
ABSTRACT
Nonalcoholic fatty liver disease (NAFLD) has become the most common form of chronic liver disease in the
developed world and affects both adults and children. NAFLD, and especially nonalcoholic steatohepatitis
(NASH), may lead to liver cancer and cirrhosis requiring liver transplant, as well as liver-, cardiovascular-, and
cancer-related morbidity and mortality, resulting in increased health burdens and associated costs. The
Nonalcoholic Steatohepatitis Clinical Research Network (NASH CRN) has been funded by the National Institutes
of Health (NIH) since 2002 and has provided important information regarding the natural history and treatment
of NAFLD/NASH in adults and children, and has set the stage for translational research focused on the
pathogenesis, diagnosis, treatment, and clinical management of these patients. This application is in response
to the Limited Competition for the Continuation of the Nonalcoholic Steatohepatitis Clinical Research Network
(NASH CRN) Data Coordinating Center (DCC) (RFA-DK-23-516). Our aims in response to the RFA are:
1) Coordinate completion of enrollment, execution, analysis, and publication of the Vitamin E Dosing Study
(VEDS) clinical trial; 2) Coordinate completion of enrollment, execution, analysis, and publication of the NAFLD
Database 3 study, including the completion of the FibroScan Spleen Stiffness Measurement and SmartExam
Software (SSMS) Substudy; and 3) Facilitate the use of biospecimen, histological, and clinical data to develop
and validate non-invasive biomarkers for the diagnosis and staging of NASH; genomic and transcriptomic data
to advance understanding of genetic predictors; and proteomic, metabolic, and lipidomic data to advance
understanding of pathogenesis and inform diagnosis, treatment, and clinical management. The DCC will provide
the NASH CRN with leadership, biostatistical analysis, study closeout, data management, multicenter
coordination, quality control, safety oversight, project support, and communication. The DCC is eager to continue
its collaboration with the Clinical Centers, NIDDK program staff, and private sector partners to complete these
important research objectives. The global hepatology community has established a new nomenclature: NAFLD
is now metabolic dysfunction-associated steatotic liver disease (MASLD), which includes patients who have
hepatic steatosis and at least one of five cardiometabolic risk factors. MetALD describes those with MASLD who
consume greater amounts of alcohol per week, and metabolic dysfunction-associated steatohepatitis (MASH) is
the replacement term for NASH. Steatotic liver disease (SLD) is an overall term covering all etiologies of
steatosis. The NASH CRN is poised to usher in this change and continue to advance the mission of the NIH to
improve the health of the public with its major impact on the field. The DCC will ensure that the NASH CRN
resources are positioned to be accessible to all researchers after the close of the network.

Public health relevance
Data Coordinating Center for the NASH Clinical Research Network (NASH CRN) Project Narrative Nonalcoholic fatty liver disease (NAFLD) encompasses a spectrum of liver disease, ranging from nonalcoholic fatty liver to nonalcoholic steatohepatitis (NASH). NAFLD is a leading cause of chronic liver disease in both adults and children, and is associated with increased liver-related morbidity and mortality. The NASH CRN aims to transform innovative scientific discoveries from clinical and translational research to better understand the natural history of the disease, develop a better means of diagnosis and treatment, understand its pathogenesis, and reduce the incidence and burden of adverse outcomes due to NAFLD and NASH.